Rice-HCC ACCELERATE: Augmenting Community College Education to Leverage Experiential Research and Advance Training Equity

Project Summary/Abstract
Academic enrichment opportunities supporting the development of critical biomedical research skills are not
widely available to college students from low-income and underrepresented minority (URM) backgrounds. This
is particularly problematic for infectious disease research since infectious diseases disproportionately impact
communities of color. In short, the current training system all but excludes the individuals who have the most
relevant lived experiences and are among the greatest stakeholders from key decision-making roles, which has
been shown to negatively affect public health. The lack of diversity at the highest levels has recently garnered
more attention—with many people pointing to a “leaky” pipeline for URM education and training. One key “leak”
that has received relatively little attention despite its enormous impact on URM student participation is the
transition from community colleges to four-year universities. With very few opportunities for specialized training
or research experience at community colleges, a vast majority of URM students at these institutions do not
pursue education beyond an associate’s degree. More than 40% of the total URM collegiate student population
is lost at this two- to four-year university transition. This partnership between investigators at Rice University and
Houston Community College (HCC) will begin “plugging” this leak by providing auxiliary professional, technical,
and experiential support for URM students enrolled at HCC—a Minority-Serving Institution that is also the fifth-
largest community college system in the United States. Importantly, this program will not only support URM
students through their transfer to a four-year university but also provide career-long mentorship to minimize drop-
out at higher levels of education and training. This program aims to Augment Community College Education,
Leverage Experiential Research, and Advance Training Equity (ACCELERATE) by recruiting, training, and
supporting diverse cohorts of biology and engineering students on the path to four-year universities, graduate
studies, and high-level job placement in the infectious disease workforce. Our program includes professional
development seminars; literature review training; a high-touch series of scaffolded laboratory modules for
technical skill-building; mentored summer research internships in labs at Rice University and the Texas Medical
Center (TMC); multi-tiered concurrent mentorship from the Program PIs, HCC faculty, TMC investigators, and
Rice postdocs and graduate students; and career development resources for HCC faculty who wish to become
research active. Through these initiatives, we will enhance students’ skills and knowledge, assist students in
building mentor and peer networks to build resilience and foster a sense of belonging, equip students with the
professional savvy necessary to pursue a career in biomedical research, support students’ applications to
transfer to four-year universities, and train faculty on how to better support URM students and scientists with the
ultimate goal of diversifying the infectious disease workforce.

Public health relevance
Project Narrative To address the glaring lack of diversity at the highest levels of infectious disease research—and with the biomedical research community in general—PIs at Rice University and Houston Community College (HCC) will Augment Community College Education to Leverage Experiential Research and Advance Training Equity (ACCELERATE) by providing enhanced opportunities to HCC students from historically underrepresented groups. Specifically, the ACCELERATE Program will consist of professional development seminars; literature review training; laboratory modules for technical skill development; mentored summer research internships in infectious disease labs at Rice University and the Texas Medical Center (TMC); and mentorship from the Program PIs, HCC faculty, TMC investigators, and postdocs and graduate students. Given these opportunities and the support of their mentor and peer networks, students will be well-positioned to transfer to four-year universities, pursue research at those institutions, gain entrance to top graduate schools, and ultimately attain leadership positions to increase the diversity of the national biomedical workforce.